Communicating Intestinal Inflammation to the Brain in Alzheimer's Disease

Project Summary
The brain communicates with the gastrointestinal tract via the well-established gut-brain axis. Due to an
increase in the permeability of blood brain barrier and intestinal epithelial barrier during aging, the brain likely
becomes more susceptible to inflammation initiated in the gut. Both chronic inflammatory bowel disease (IBD
including ulcerative colitis and Crohn's disease) and Alzheimer's disorder (AD) increase in prevalence among
the elderly. However, the role of this intestinal inflammation on AD progression remains unclear. We observed
a significant increase in intestinal inflammation and dysfunction during disease in a mouse model of AD. Based
upon this data we hypothesize that AD includes intestinal dysfunction as a largely unrecognized component of
disease. Moreover, we expect that chronic conditions such as IBD may potentiate progression of AD through
inflammatory changes propagated from the intestines to the brain. We will elaborate the link between the
intestines and the brain in AD using a transgenic mouse model of AD, AppNL-G-F mice. Our hypothesis will be
tested by completing three aims. Aim one will use clinically available intestine-selective T cell inhibitory
antibodies to attenuate basal AD intestinal inflammation and colitis-induced exacerbation in AppNL-G-F mice and
confirm that intestinal dysfunction contributes to memory deficits in these mice. Aim two will assess the efficacy
of the gut-selective inhibitory antibody therapy to decrease brain Aβ levels, gliosis, synaptic loss, and cytokine
levels. The final aim will cross the AppNL-G-F mice to Ltatm1Dch mice that carry a null mutation in lymphotoxin α
resulting in absence of Peyer's patches and lymph nodes. This genetic approach will provide additional
confirmation that intestinal inflammatory changes in the AppNL-G-F mice are required for the memory dysfunction
and brain related changes. Completion of the study will verify a critical role of gut inflammation in disease
progression and validate a clinically available therapeutic option, anti-α4β7 antibodies, as treatments targeting
the gut-brain axis. This suggests that select immunomodulatory agents can be repositioned to combat the
inflammatory component of AD without the need for crossing the blood brain barrier.

Public health relevance
Narrative Alzheimer's disease (AD) is the most common age-associated neurodegenerative disease in the U.S. Since the brain and gastrointestinal tract influence each other, it is important to know whether intestinal dysfunction elevates the risk or progression of AD. Using a mouse model of Alzheimer's disease, we will determine whether basal disease-associated intestinal inflammation contributes to brain presentation of disease and whether exacerbating intestinal dysfunction by inducing inflammatory bowel disease potentiates the severity of brain changes. More importantly, we will determine whether available strategies for modulating intestinal inflammation can prevent its influence on progression of AD. This study will define a new understanding of how AD develops and provide a new therapeutic approach to prevent it.